IMPACT OF LIFE EVENTS ON PATTERNS OF DRUG US IN AN URBAN AFRICAN AMERICAN COHORT

DESCRIPTION (provided by applicant): A critical but understudied area of research is why people stop using drugs, especially African American adults. This question is the primary focus of the proposed study. African Americans have the same or less substance use as adolescents compared to Whites, but as they age into adulthood they are more likely than Whites to initiate drug use, less likely to desist use, and more likely to develop use disorders. Moreover, drug use significantly impacts health, with adult drug use problems being more evident in older African Americans than in Whites, such as higher drug-related mortality and morbidity. We address this important public health issue using data spanning more than 35 years from a comprehensive developmental epidemiological study of a community cohort of urban African Americans first studied at age 6 (N=1242), then in adolescence, and at ages 32 and 42. This inner city Chicago cohort represents a 1960 birth cohort, considered to have the highest rates of adolescent drug use. Information from mothers, teachers, and official school, criminal, and death records are integrated with data from cohort members to build a study that provides an invaluable opportunity to examine the impact of life events on patterns of substance use over the life course. The specific aims are to: 1) examine the impact of individual life events on long-term patterns of drug use; 2) identify conditions under which life events impact long-term drug use patterns, and 3) determine what individual-level or contextual factors moderate the impact of life events on long-term patterns of drug use. The proposed project draws on the age-graded theory of social control from criminological literature and applies it to substance use, extending our understanding of the relationship between social ties and desistance from deviance (Sampson & Laub, 1993; Laub & Sampson, 2003). Few positive life events beyond marriage, work, and military service have been studied in this regard, and there has been little to no attention paid t negative life events. Thus, we seek to study a wider array of life events, both positive and negative, that can alter substance use and investigate conditions under which life events impact substance use patterns. This work will extend our understanding of the role of social ties stemming from individual life events as potential turning points in substance use. Yet, not everyone who experiences a life event will alter their substance use trajectory. Prior research has found the quality of life events to matter. In this project, we investigate additional conditios under which life events impact substance use desistance such as the quantity and combinations of life events, and timing and ordering of life events. We also investigate moderating effects from stable individual differences (e.g., self-control) and adult contextual influences (e.g., histry of depression). The proposed project uses longitudinal methodologies (e.g., hierarchical linear modeling) and adopts a person-oriented approach, considering the individual as a whole to better understand stability and change in substance use. Findings will inform intervention development by identifying pivotal influences in adulthood that facilitate desistance from substance use.

Public health relevance
Knowledge about influences leading to desistance from substance use is critical, especially among African Americans, who as they age into adulthood are more likely than Whites to initiate drug use, less likely to desist use, and more likely to develop use disorders. Moreover, African Americans experience disproportionately poorer health and higher mortality in mid adulthood often related to their drug use, which is of great public health significance. By exploring a wide array of life events that can alter substance use, this research spanning more than 35 years in the lives of a community cohort of African American men and women will make unique and important contributions to understanding why people stop using drugs and in turn inform intervention development.